Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools

Overall
PROJECT SUMMARY / ABSTRACT
The University of California (UC) Davis Nonhuman Primate Testing Center for Evaluation of Somatic Cell
Genome Editing Tools will support studies in nonhuman primates that will advance the genome editing field,
and significantly contribute to the future translation of these technologies for the treatment of human disease.
The Nonhuman Primate Testing Center brings together a robust team of multidisciplinary investigators with
campus partnerships that capitalize on major strengths at UC Davis including the California National Primate
Research Center, Genome Center, and Clinical and Translational Science Center. The Nonhuman Primate
Testing Center will offer state-of-the-art capabilities for Somatic Cell Genome Editing (SCGE) awardees to
conduct high quality research in nonhuman primates. The Nonhuman Primate Testing Center leverages a
supportive framework that has demonstrated a long-standing commitment to providing research opportunities
and collaborations to investigators nationwide. Through this powerful infrastructure the Nonhuman Primate
Testing Center proposes the following Specific Aims: (1) Provide an administrative and organizational structure
to advance somatic cell genome editing studies in nonhuman primates, (2) Foster partnerships with SCGE
awardees through provision of resources that accelerate their research, and (3) Ensure synergism across the
SCGE Program and Consortium via transparent interactions with the Dissemination and Coordinating Center,
SCGE Working Group and Program Steering Committee, and the NIH. Our robust multidisciplinary team is
poised to bring the depth and breadth of the UC Davis Nonhuman Primate Testing Center for Evaluation of
Somatic Cell Genome Editing Tools to support SCGE investigators nationwide and contribute substantially to
the Common Fund SCGE Program.

Public health relevance
Overall PROJECT NARRATIVE The UC Davis Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools will serve the Somatic Cell Genome Editing community and the public by supporting studies in nonhuman primates that will advance the field. Through these efforts the Nonhuman Primate Testing Center will significantly contribute to the future translation of cutting-edge technologies for the treatment of a range of rare and common human diseases.